Endocannabinoid Targeting for Opioid Induced Respiratory Depression

Project Summary
Accidental overdoses fatalities define the opioid epidemic despite research efforts for alternative means to
address Opioid Use Disorder [1] and alternative chronic pain therapies [2]. The Centers for Disease Control
report over 400,000 lives lost since 1999 and more than 130 people lose their life to an accidental overdose daily
[3]. This number will continue to climb with excessive utilization of prescription opioids and the presence of
stronger synthetic opioids in the illicit market [4-6]. A potentially fatal opioid overdose can be successfully
reversed with naloxone, mu opioid receptor antagonist, [7], but with the number of pain patients rising above
heart disease and diabetes [2] and the increased presence of fentanyl in the illicit opioid market, adequate
distribution of naloxone to reverse an overdose before oxygen deprivation occurs remains difficult [8]. Attempts
to reduce opioid overdoses with novel opioid-like compounds have been largely unsuccessful [9]. Therefore, it
is essential that unexplored therapeutic strategies to prevent opioid-induced respiratory depression be
discovered.
Fatal opioid overdoses are typically attributed to respiratory depression, during which neurons within the
preBötzinger complex (pBc) in the brainstem that control reflexive inspiration are inhibited. Our pilot data suggest
that 1) the pBc contains the components of the endocannabinoid system, including the cannabinoid receptor 2
(CB2R), 2) CB2R activation by endogenous cannabinoid system (ECBS) lipids is critical to normal respiration
control, and 3) exogenous application of a CB2R agonist mitigates morphine induced respiratory depression.
The current proposal will build upon these findings, using behavioral pharmacology, whole body
plethysmography, imaging, molecular biology, analytical chemistry, and gene-editing to test the hypothesis that
endogenous cannabinoid levels in the pBc are reduced during opioid induced respiratory depression
(OIRD) and that administration of a brain penetrant CB2R agonist will mitigate OIRD. Aim 1 will test CB2R
agonism as a strategy to mitigate to OIRD. Each aim contains rationally designed studies that include sex
differences through inclusion of male and female mice, application to both acute and chronic use of medicinal
and recreational opioids (fentanyl, oxycodone, and heroin), and multiple chemical classes of CB2R agonists to
prevent and reverse OIRD. Aim 2 will determine levels of endocannabinoid lipids, enzymes, and receptors in
the preBotzinger complex (pBc) during OIRD. Successful completion of proposed studies will serve to
enhance our knowledge of the role of ECBS within the pBc in during normal respiration and during OIRD
and validate targeting the CB2R as a safe treatment therapeutic to reduce opioid overdoses.

Public health relevance
Project Narrative The US is facing an unprecedented loss of life resulting from opioid overuse and the associated respiratory depression (OIRD). This project will investigate targeting the cannabinoid receptor 2 (CB2R) as a novel therapeutic target to mitigate OIRD induced by three commonly used recreational and medicinal opioids - fentanyl, oxycodone, and heroin. Successful completion of proposed experiments will 1) reveal the mechanistic role of the endocannabinoid system within the brainstem in regulating breathing under normal and OIRD states and 2) validate activation of the CB2R as a safe and clinically useful therapy for opioid use disorder (OUD).